Florida International University MARC U*STAR Program

ABSTRACT
The proposed Florida International University (FIU) MARC U*STAR Plan is designed to address the national
deficiency of diversity in the biomedical workforce. It will teach practical, career enhancing skills and
addresses these in the context of often overlooked, underlying issues such as social capital and self-identity,
to demonstrate biomedical research as a rewarding career path--providing life skills needed to succeed in this
arena. FIU is a public, research institution (R1 Carnegie Classification Doctoral University - Highest Research
Activity) located in Miami, Florida. It has an enrollment of 53,000 students (fall 2017), is designated an
Hispanic Serving Institution (64% Hispanic), emphasizes research in its mission and includes health and
diversity as strategic themes. The mission of the MARC U*STAR Program is to enhance the pool of UR
students earning baccalaureate and Ph.D. degrees in biomedical research fields and ultimately to contribute
to the diversification of the nation’s scientific workforce. Therefore, our vision is to provide a structured
training program to prepare high achieving UR students for Doctoral Programs in Biomedical research fields.
We will achieve this by providing an authentic research experience, academic enhancements and skill
development, as well as close mentoring and advising. The program provides motivated, honors
undergraduate juniors and seniors from underrepresented groups with tools, skills, and a sense of belonging,
that will allow each to successfully enter, excel in, and complete a biomedical or behavioral sciences Ph.D. or
M.D./Ph.D. program. This will be accomplished by immersing each MARC U*STAR trainee in a supportive &
stimulating research lab of an active researcher with a successful undergraduate mentoring record, who will
develop the individual student’s skills, and properly nurture and enhance the trainee’s interest in science over
a two-year period, culminating with an honors thesis. The MARC U*STAR program will provide a monthly
stipend and partial tuition waiver, eliminating the need for trainees to seek outside employment and enable
them to focus on their research projects and enrichment activies. The program will supplement the trainees’
FIU academic year research experience with: personal advising, bi-weekly program meetings, professional &
academic development workshops, technical skills workshops, travel to scientific meetings, scientific
presentation venues, networking opportunities, leadership opportunities, community outreach events, and
facilitiate participation in an extramural summer research program. Six trainees will be selected each year
from targeted departments including Biology, Chemistry, Psychology and Biomedical Engineering. Each year,
the six seniors will serve as peer mentors to the six incoming juniors--a key element for building their network,
enhancing their mentoring and building their self-identity as a scientist. FIU provides an excellent
environment and opportunity to develop a significant number (24 over the 5-year funding period) of well-
rounded, underrepresented scientists for biomedical research careers.

Public health relevance
NARRATIVE FIU’s MARC U*STAR Program provides motivated, honors undergraduate juniors and seniors from underrepresented groups with tools, skills, and a sense of belonging that will allow each to successfully enter, excel in and complete a biomedical or behavioral sciences Ph.D. or M.D./Ph.D. program. This will be accomplished by immersing each MARC U*STAR trainee in a supportive & stimulating research lab of an active researcher with a successful undergraduate mentoring record, who will develop the individual student’s skills and properly nurture and enhance the trainee’s interest in science. The MARC U*STAR program will: supplement the trainees’ FIU scientific research experience with personal advising; conduct bi-weekly program meetings; offer professional & academic development workshops, technical skills workshops; sponsor seminars and opportunities for scientific presentations; provide networking opportunities, leadership opportunities, community outreach events; and facilitiate participation in a summer research program at an extramural research-intensive university.